SimplePath II: A Cell-free Enzymatic Platform for Cannabinoid Biosynthesis

Project Summary
Cannabinoids (CNs) are bioactive natural products with many current and potential theoretical therapeutic uses
that are generally extracted from natural plant sources. While the CNs tetrahydrocannabinolic acid (THCA), and
cannabidiolic acid (CBDA) are the highest abundance and therefore the most well studied, there are many other
low abundant (rare) cannabinoids that are also made in plants (e.g. cannabigerolic acid (CBGA) and the “varins”
cannabidivarinic acid (CBDVA) and tetrahydrocannabivarinic acid (THCVA). Plant production of CNs,
particularly rare CNs, is problematic because of crop variability, purification challenges and environmental
concerns. Consequently, there is considerable interest in producing both common and rare CNs by metabolic
engineering of microbes. Microbial production of CNs also faces daunting challenges, however, and published
titers so far are several orders of magnitude below cost competitive levels (8 mg/L).
Invizyne Technologies is developing an alternative, cell-free method to produce common and rare CNs (and
other natural products) using enzymatic transformations. Our primary focus is production of the central CN
precursors CBGA and cannabigerovarinic acid (CBGVA), because a variety of important CNs can be produced
from CBGA/CBGVA in single enzymatic steps. Moreover, CBGA itself is bioactive and shows promise for
treatment of glaucoma, inflammatory bowel disease, and Huntington’s disease among other indications.
A key barrier to cell-based and cell-free production of CNs has been twofold. First, reliance on the native
membrane protein to make CBGA, Geranyl:Olivetolate Transferase (GOT). Second, biosynthesis of CBGA
requires synthesis of two complex and essential intermediates, olivetolic acid (OA) and geranyl pyrophosphate
(GPP). In a major development, we were able to design a highly active, specific and water soluble GOT enzyme.
With this soluble GOT enzyme, we designed a 7 enzyme system for the production of CBGA from low cost
inputs, that we call SimplePath. Initial Phase I results yielded CBGA titers well over 12 g/L, exceeding cell-based
methods by several orders of magnitude and suggesting SimplePath is suitable for commercial development.
Our goal in this Phase II application is to expand our SimplePath approach and make necessary improvements
to lower costs, improve titers, and broaden the number and type of products produced. At the end of Phase II
we will perform techno-economic analysis on the optimized SimplePath system to guide commercialization
efforts (and identify other weak points) that will be addressed in a Phase III or pilot scale project. Phase II work
is necessary for establishing a consistent, highly pure supply of a range of CNs to be used as therapeutics or
nutraceuticals at costs that can compete with or surpass both microbial and plant derived CN production.

Public health relevance
Project Narrative Our Phase II SBIR proposal will expand our novel cell-free route to cannabinoids (CNs) to enable production of both common and rare CNs at high titer and high purity necessary for study and development of CNs as therapeutics. We will employ a proprietary, highly active, specific, and soluble enzyme to produce common and rare CNs from low cost inputs using a simplified cell-free enzymatic system that we call SimplePath. Our innovative approach will make rare CNs and other previously inaccessible natural products available to research and commercial markets. Additional Phase II work will focus on finding alternative routes and lowering costs of specific inputs. Work in this Phase II is essential to confirm that cell-free production of natural products is a robust and easy to use system for the commercial production of difficult to source natural products such as CNs.